Mapping the neuronal circuitry underlying indirect striatal to hypothalamic connectivity and its role in feeding

Food consumption is fundamental to species survival and understanding the neuronal circuitry underlying
feeding behaviors is of the utmost importance. Amassing evidence supports the idea that control of caloric
intake is complex and involves calculations of hedonic value, reward and motivation. Thus, it requires
interactions between brain regions classically implemented in feeding (such as the lateral hypothalamus; LH)
and the regions modulating reward (such as the ventral striatum). While the intersection of these regions has
been suggested, the cell-type specific circuitry linking these pathways is poorly understood. The objective of
this proposal is to further elucidate the cell-type specific circuitry underlying striatal-to-lateral hypothalamic
connections and determine its role in feeding, while gaining training in new neuronal circuitry mapping
techniques.
There is evidence that the striatum exerts its control over feeding behaviors by interfacing with the LH.
Previous research indicates that the ventral striatum, and specifically the nucleus accumbens shell (NAcS),
and the LH are connected via a direct pathway. However, rudimentary tracing and behavioral studies have
suggested a second, indirect pathway, with the NAcS projecting to the ventral pallidum (VP), which in turn
projects to the LH. However, despite this initial evidence, cell-type specific, neuronal circuitry in this indirect
pathway remains unknown. Using viral tracing methods and chemogenetic approaches I will determine the
cell-types implicated in each component of this three-part circuitry, and how they mediate feeding behaviors. I
hypothesize that GABAergic striatal projection neurons expressing the dopamine D2 receptor in the NAcS
preferentially innervate GABAergic cells in the VP, which in turn disinhibit LH GABA neurons to facilitate
feeding.
Furthermore, in understanding the brain pathways and connectivity underlying food intake behaviors, this
project will ultimately allow us to better understand perturbations that occur in disease states such as obesity.

Public health relevance
Food consumption is rudimentary to species survival and understanding the neuronal circuitry underlying feeding behaviors is of the utmost importance. The regulation of food intake requires interactions between brain regions classically implemented in feeding (such as the lateral hypothalamus) and the regions modulating reward (such as the ventral striatum). The objective of this proposal is to further elucidate the cell-type specific circuitry underlying striatal-to-lateral hypothalamic connections and determine its role in feeding, while gaining training in new neuronal circuitry mapping techniques.